Interactive roles of cardiorespiratory fitness and adiposity on recovery of impaired glucose and vascular control after physical inactivity

Project Summary
The far-reaching negative health effects of the reduced physical activity (RPA) epidemic are often
overlooked by the general population and health professionals. Short-term RPA induces
cardiometabolic dysfunction, including impaired glucose control and vascular function, that may
precede disease development. The impact of existing health status on RPA-induced
cardiometabolic dysfunction and recovery of impaired glucose control following RPA is
unexplored. Thus, our objectives are 1) to investigate the effect of existing health status
(cardiorespiratory fitness and adiposity) on the recovery of impaired glucose control following a
period of RPA and 2) to determine the role of vascular function as a mechanism of impaired
glucose control. Our final objective is to 3) expose undergraduate students to meritorious
biomedical clinical research methods. We have piloted the clinical research methods and analysis
with undergraduate researcher associates and are well-prepared to complete this proposal. Our
preliminary data show that low cardiorespiratory fitness and/or high adiposity impair the recovery
of glucose control following short-term RPA. Thus, we aim to examine the interactive role of health
status (cardiorespiratory fitness and adiposity) on the ability to recover impaired glucose control
following short-term RPA. We also seek to examine changes in vascular function as a mechanism
of recovery of impaired glucose control following a return to normal PA. We will recruit men and
women with divergent health status (cardiorespiratory fitness and adiposity) to examine glucose
control and vascular function during 7-d of normal PA, 7-d of RPA, and 7-d of resumption of
normal RA. Continuous glucose monitoring and oral glucose tolerance tests will be performed to
assess glucose control. Increases in vascular shear stress induced by passive leg movement and
central arterial stiffness will be measured to assess vascular function.

Public health relevance
Project Narrative This project is relevant to public health because the detrimental effects of reduced physical activity. are vastly undervalued and ignored by most of the population. Reduced physical activity diminishes muscle and metabolic function. This reduced function is normally restored in the healthy person, but at some point during declining health, that return to normal metabolic function is impaired. This inability of unhealthy persons to recover from reduced physical activity represents a pivotal area to investigate and intervene to stop the progression of metabolic disease.